BCS Core

Project Summary
The Biospecimen Core directed by the Director of the Biobanking and Correlative Sciences (BCS) Core at
Karmanos Cancer Institute, Dr. Julie Boerner, PhD and co-directed by Dr. Fulvio Lonardo, expert lung cancer
pathologist will provide the highest quality biological specimens to support the research of investigators for this
P20 application. This Core facility is charged with collecting, banking, and transferring fresh and frozen human
tissue samples for investigative purposes. As part of this process, the Biospecimen Core will provide correlative
clinical information for biospecimens while maintaining strict patient confidentiality, using the well-established
Honest Broker system, and ensuring that requesting investigators have proper protocol review and IRB approval.
This specific collection of biospecimens is focused on overcoming the lack of biospecimens from minority
patients that plagues race/ethnicity-related researcher questions. The goal of this P20 SPORE Core is to ensure
that high-quality biospecimens, collected while ensuring compliance with federal and institutional guidelines, are
delivered in a timely manner to P20 SPORE investigators and to provide pathologic and molecular analytic
expertise to support the innovative and translational cancer health disparities research projects in this
application. The specific aims of Biospecimen Core are the following: Specific Aim 1: To collect, process and
bank cancer tissue and associated biological samples with ongoing quality control to ensure timely distribution
of appropriately diagnosed, high-quality samples to investigators and collaborators on all P20 SPORE projects
for molecular and genomic analysis, for culture and for xenograft assays, and for ancestry informative markers
to further define patient race; Specific Aim 2: Perform high quality immunohistochemical staining and provide
pathological interpretation of stained tissue sections to investigators and collaborators on all P20 SPORE
projects; Specific Aim 3: Generate tissue microarrays using samples from African American cancer patients for
use in future projects and made available to the broader research community to support expanded efforts in the
reduction of cancer health disparities; Specific Aim 4: To maintain and update a central Detroit P20 SPORE
database of biospecimens from cancer patients collected at KCI that is annotated with demographic, clinical,
and pathologic data, and provide access to data and specimens; and Specific Aim 5: To actively participate in
the design of pathology/ancillary studies of P20 SPORE projects, the Developmental Research Program
projects, and projects for consideration for a full P50 SPORE application, including providing input on suitability
for samples for studies proposed, histologic characterization, immunohistochemical analyses, and microscopic
scoring, and construction of study specific tissue microarrays. Together, these aims will allow the Biospecimen
Core to have a significant clinical impact in this P20 application, as it has a large collection of valuable and
appropriate specimens that are immediately available to the research projects.

Public health relevance
Project Narrative The Biospecimen Core's goal is to ensure that high-quality biospecimens, collected while ensuring compliance with federal and institutional guidelines, are delivered in a timely manner to P20 SPORE investigators and to provide pathologic and molecular analytic expertise to support the innovative and translational cancer health disparities research projects in this application.